The circuit basis of sundowning-related circadian dysfunction in Alzheimer's disease and Alzheimer's disease-related dementias

The long-term goal of this project is to gain an understanding of the circuit mechanisms underlying circadian
dysfunction and associated behavioral disturbances in Alzheimer’s disease (AD) and Alzheimer’s disease
related dementias (ADRD). AD/ADRD are associated with progressive disruption of circadian rhythms,
including body temperature, locomotor activity, and other rhythms, compared to healthy aged-matched
controls. This suggests that AD-related pathology alters the ability of the master circadian pacemaker (the
suprachiasmatic nucleus of the hypothalamus, SCN), to synchronize such rhythms to the daily light-dark cycle.
A particular form of circadian dysfunction in around 20% of AD/ADRD patients is “sundowning”, characterized
by agitation, aggression, and wandering during the late afternoon and early evening. The neurobiology of
sundowning remains unknown, but our lab has developed a working model for how disruption of circadian
pathways in mice may lead to temporal disturbances relevant to sundowning. The SCN is known to regulate
body temperature and locomotor activity rhythms by a pathway through its major postsynaptic target, the
subparaventricular zone (SPZ). We recently showed that aggression propensity in mice also follows a daily
rhythm regulated by the SCN and SPZ through a separate downstream pathway. Importantly, disrupting this
pathway increases aggression around the active-to-rest phase transition, which is temporally analogous to
when sundowning patients show agitation and aggression. AD-associated disruptions to the SCN, SPZ, or their
input pathways, may thus lead to disturbances in body temperature, locomotor activity (in the form of
wandering), and also sundowning-related aggression. To address potential mechanistic connections between
AD-related pathology and circadian function, we conducted behavioral and neuroanatomical analyses in the
TAPP mouse model of AD. We identified the lateral parabrachial nucleus (LPB) in the brainstem as a major
site of pTau, found that the LPB projects to both the SCN and SPZ, and reveal strong evidence of a role for
LPB pTau in AD-related circadian dysfunction and aggression. Here, we will test our hypotheses that the
LPBàSCN/SPZ pathway is required for normal circadian function and that pTau in this pathway underlies AD-
related circadian dysfunction and sundowning-related behavioral disturbances. We will use retrograde delivery
of Cre recombinase from the SCN and SPZ, and Cre-dependent vectors in the LPB to specifically manipulate
LPBàSCN/SPZ neurons. We will determine if chemogenetic manipulations of LPBàSCN/SPZ neurons acutely
ameliorate or exacerbate circadian dysfunction and increased aggression in TAPP mice. We will also express
the P301L mutation (and subsequently pTau) in only LPBàSCN/SPZ neurons in wild-type mice and in mice with
high levels of a-beta to examine interactions between pTau and a-beta in this pathway. Finally, we will use
Cre-mouse lines to target specific LPB subpopulations that differentially project to the circadian system to
determine their respective roles in normal circadian function and pTau-related circadian dysfunction.

Public health relevance
Project Narrative Sundowning syndrome, characterized by agitation, aggressiveness, and wandering during the late afternoon and early evening, occurs in about 20% of Alzheimer’s disease (AD) and Alzheimer’s disease-related dementias (ADRD) patients and often leads to institutionalization. Using mouse models of AD/ADRD and other transgenic mouse lines, we will examine the role of a novel neural pathway from the brainstem to the circadian system in temporal disturbances of body temperature, locomotor activity, and behavioral aggression that are relevant to those seen in sundowning. This project may lead to a better understanding of sundowning-related circadian dysfunction and may suggest an eventual therapy that could greatly improve the quality of life for AD/ADRD patients and their caregivers.